RISE: Educating Tomorrow's Biomedical Workforce

Program Summary. Morehouse School of Medicine (MSM) has established a strong track
record of achievement in both research and education. Our efforts have been impactful in
training the next generation of biomedical scientists and in enhancing the diversity of the
biomedical research workforce locally and nationally. The MSM RISE Program has been an
integral component in providing the resources and support for maintaining this track record in
research training. The overall goals of MSM’s RISE Program are to enhance research training in
biomedical and behavioral sciences and to increase the number of students from
underrepresented groups who successfully complete PhD programs in these fields. The specific
goals and objectives of the proposed program are: Goal 1- Support pre-doctoral graduate
students in completing the PhD program with the knowledge base and skill set that will
make them competitive for research-based postdoctoral positions and research grant
support. This goal will be addressed through the following objectives: 1.1- Enhance scientific
writing, critical thinking and communication skills; 1.2- Promote and foster active learning to
enhance critical thinking skills; 1.3- Utilize the breadth and strength of the MSM research
enterprise and our partners to enhance training of pre-doctoral students; and 1.4- Provide
opportunities that will enhance students’ understanding of Big Data Science. Goal 2- Leverage
Student Learning Communities and the Office of Career Connections to enhance the
graduate experience and prepare RISE Scholars for academic and non-academic
biomedical careers. The following objectives will address this goal: 2.1- Enhance networking
skills and opportunities for constructive feedback; 2.2- Enhance student leadership development
and management skills; 2.3- Leveraging the Office of Career Connections (OCC) to prepare
students for academic and non-academic biomedical careers.
To accomplish these goals and objectives, the RISE Program will include hands-on, focused
skill development workshops; fellowship application development mini-camps; and active
learning training for investigators. Sponsored seminars will include: State-of-the-Sciences
seminars given by scientific leaders in their respective fields; student-led seminars to develop
scientific presentation skills; and career development seminars. Additionally, the RISE Program
staff will be actively involved in enhancing the academic experience of graduate students
through Learning Communities, career exploration via the Office of Career Connections and will
provide a gateway for exposure to the rapidly developing field of big data science.
Based on the institutional goal of increasing enrollment in the PhD program by 20% over the
next five years, we propose to increase the number of RISE students supported by 50% over
the next five years. Students selected as RISE scholars will receive up to five years of salary
and tuition support. The anticipated milestones include: increased numbers of abstracts
accepted for presentation and increased numbers of published manuscripts; an average
graduation rate of 90% for RISE Scholars, with an average of 80% of these graduates entering
research-based post-doctoral positions and jobs; development of a graduate data science
curriculum; and expansion of the mentor pool for RISE Scholars and the overall graduate
program.

Public health relevance
Project Narrative. The overall goals of Morehouse School of Medicine’s RISE Program are to enhance research training in the biomedical and behavioral sciences and to increase the number of students from underrepresented groups who successfully complete PhD programs in these areas. The specific goals of the proposed program are to: support pre-doctoral graduate students in completing the PhD program with the knowledge base and skill set that will make them competitive for research-based postdoctoral positions and research grant support; and leverage student Learning Communities and the Office of Career Connections to enhance the graduate experience and prepare RISE Scholars for academic and non-academic biomedical careers.